Leveraging mHealth to deliver integrated pain-CBT, opioid monitoring, and self-management support for advanced cancer patients coping with chronic pain

Project Summary
Pain affects approximately two thirds of patients with advanced cancer, with rates approaching 90% near the
end-of-life. Although pharmacotherapy is vitally important to alleviating chronic cancer pain, psychological
factors also substantially influence pain outcomes. Cognitive Behavioral Therapy for pain (pain-CBT) is
effective for chronic cancer and non-malignant pain. Unfortunately, pain-CBT in its traditional format (60-
minute, in-person sessions for 12-16 weeks) is unrealistic for advanced cancer patients. Effective
biopsychosocial cancer pain management requires substantial adaptation to meet the real-life needs of
advanced cancer patients and should ideally integrate with pharmacotherapy support. Given the expansive
need, mobile health technology is a promising strategy to deliver and ultimately disseminate brief, pain-CBT
interventions to cancer patients.
Our goal is to improve advanced cancer patients' pain self-management by adapting and integrating pain-CBT
into our existing mHealth program designed to support patients' pharmacologic management. Our parent
intervention, STAMP (Smartphone Technology to Alleviate Malignant Pain) is a patient-facing smartphone
application that supports daily symptom and opioid monitoring, and delivers tailored pain psychoeducation and
advice. We have a strategic opportunity to adapt and integrate pain-CBT to create novel mHealth intervention
that harmonizes psychological and medical support for advanced cancer pain. Leveraging mobile technology,
we will simulate the therapeutic experience of pain-CBT by 1) presenting advanced cancer-specific, multimedia
psychoeducational content, 2) developing schedules to deliver daily, brief didactics, 3) facilitating insight
building via surveys and tailored feedback, & 4) stimulating active learning through gamified cognitive
restructuring exercises and audio-recorded relaxations. In Aim 1: We will supplement our multi-media library of
cancer pain psycho-education and adapt pain-CBT content for brief mHealth delivery specific to advanced
cancer, while integrating clinician and patient (n=20) feedback throughout. In Aim 2: 25 patients with chronic
pain from advanced cancer will use STAMP+CBT for 6 weeks. Findings will illuminate feasibility of app use
and data collection for a larger future efficacy trial (R01), allowing for exploration of meaningful trends in pain,
psychological mediators, and care utilization. If proven effective, this pain-CBT and opioid management
intervention has great potential to scale and make biopsychosocial pain treatment available to a population that
suffers disproportionately from chronic pain and has little access to non-pharmacologic pain management
treatments.

Public health relevance
PROJECT NARRATIVE Chronic pain, a common and distressing complication of advanced cancer, is commonly treated with analgesics with minimal access to comprehensive biopsychosocial pain management approaches. This proposal seeks to improve advanced cancer patients' pain self-management by adapting and integrating pain- CBT into an existing mHealth intervention designed to optimize pharmacologic management (e.g. opioid monitoring and advice). In line with the NIH Federal Pain Research Strategy, NAS pain report, and public health needs, this proposal ensures a biopsychosocial approach to treating advanced cancer pain by integrating psychological and pharmacologic treatment approaches within an mHealth intervention, and following an efficacy trial could readily disseminate and alleviate pain for this vulnerable population.